Dysregulation of Wnt signaling in subretinal fibrosis in AMD

7. PROJECT SUMMARY/ABSTRACT
Previous studies by others and us have shown that aberrant activation of the canonical Wnt pathway is
associated with age-related macular degeneration (AMD) in human patients and in animal models.
Furthermore, we have shown that blockade of Wnt signaling partially attenuated retinal inflammation, vascular
leakage and neovascularization (NV) in the laser-induced choroidal neovascularization (CNV) model,
suggesting that dysregulation of Wnt signaling plays a key role in retinal inflammation, vascular leakage and
NV. However, the mechanism for the dysregulation of Wnt signaling in AMD remains elusive. We have
previously shown that very low-density lipoprotein receptor (VLDLR) gene knockout (KO) resulted in Wnt
signaling over-activation, retinal inflammation, vascular leakage and sub-retinal NV. Our preliminary studies
demonstrated that Vldlr KO induced fibrotic factor expression in the RPE. In addition, we showed that VLDLR
is expressed predominantly in rod photoreceptors and sheds its soluble N-terminal ectodomain (sVLDLRN)
into the inter-photoreceptor matrix (IPM) to modulate Wnt signaling inter-cellularly. sVLDLRN levels in the IPM
are reduced in the CNV model and a dry AMD model. Therefore, we hypothesize that the reduced sVLDLRN
shedding into the IPM may result in Wnt signaling over-activation in the RPE, leading to retinal inflammation,
vascular leakage, sub-retinal NV and fibrosis in AMD. In this project, we will determine if the decreased
sVLDLRN shedding from photoreceptors in AMD represents a new pathogenic mechanism for retinal
inflammation, vascular leakage, sub-retinal NV, and fibrosis through over-activation of Wnt signaling.
Specifically, we will use our newly generated transgenic mice expressing sVLDLRN in rod photoreceptors and
secreting sVLDLRN into the IPM to study if over-expression of sVLDLRN in rods will attenuate Wnt signaling
over-activation, retinal inflammation, vascular leakage, sub-retinal NV, and fibrosis in AMD models.
Furthermore, we will determine if Vldlr KO only in rod photoreceptors is sufficient to induce over-activation of
Wnt signaling in the retina and RPE, leading to retinal inflammation, vascular leakage, sub-retinal NV, and
fibrosis. We also propose to investigate if sVLDLRN confers an anti-fibrotic effect through inhibition of
epithelial-mesenchymal transition induced by Wnt signaling. To explore how sVLDLRN modulates Wnt
signaling, we will define the predominant Wnt co-receptor contributing to pathologies in AMD with Lrp5 KO and
Lrp6 KO RPE cell lines generated using the CRISPR-Cas9 system. We will also define the Wnt receptor
responsible for the interaction with sVLDLRN to inhibit Wnt signaling. This project will establish a new
pathogenic mechanism for Wnt signaling dysregulation, retinal inflammation, vascular leakage, CNV, and sub-
retinal fibrosis in AMD and identify an intercellular crosstalk between RPE and photoreceptors which
modulates Wnt signaling through sVLDLRN shedding. These studies have potential to identify a new
therapeutic target for sub-retinal fibrosis in AMD.

Public health relevance
8. PROJECT NARRATIVE This project aims to identify a pathogenic pathway mediating fibrosis in age-related macular degeneration (AMD). Since fibrosis is a major cause of blindness in AMD patients, the proposed studies will enhance our understanding of this blinding disorder. The information generated from this project will also reveal a new drug target for the treatment of subretinal fibrosis to prevent vision loss in AMD patients.